Receipt of Guideline Concordant Surveillance in Young Colorectal Cancer Patients.

Despite advances in CRC care over the last two decades, differences in the incidence and mortality from colorectal cancer (CRC) between younger and older patients in the U.S. continue to persist. Existing research highlights differences in the incidence, stage at diagnosis, survival rates, and access to treatments for younger patients with CRC. Younger survivors may also have distinct survivorship concerns compared to their older counterparts. However, the specific needs and priorities of these young survivors remain underexplored. In this study we will utilize Michigan Cancer Surveillance Program (MCSP) Clinical Registry and Michigan Value Collaborative (MVC) Administrative Claims Data to examine contemporary survivorship patterns in younger colorectal cancer survivors. We will specifically examine rates of National Comprehensive Cancer Network (NCCN) guideline concordant surveillance among young colorectal cancer survivors, examining clinical and demographic factors associated with non-receipt of guideline concordant surveillance (Aim 1). We will then interview a cohort of young colorectal cancer survivors diagnosed with stage I-III CRC and underwent surgery from 2018-2022 (Aim 2). This study will yield much-needed population-based estimates of surveillance intensity and survivorship care needs young cancer survivors.

Public health relevance
PROJECT NARRATIVE This proposal will utilize large and diverse claims-based samples of patients with early-onset colorectal cancer to examine the impact of colorectal cancer treatment and its survivorship care among younger adults of racial and ethnic minorities and identify the unmet needs of racial and ethnic minority early onset colorectal cancer survivors. Importantly, our findings may also be applied broadly to other cancers affecting younger minoritized patient populations with similarly burdensome symptoms and treatment-related effects.